CARDIOVASCULAR RESPONSE TO DAILY STRESS IN WORKING WOMEN

The purpose of this research is to examine how psychological and behavioral factors associated with ethnicity (black, white) contribute to the diurnal blood pressure variability in women.